Mechanism of Muscle Wasting in Aging Man

Abstract The aging population is rapidly expanding in our society, and sarcopenia contributes to physical frailty and cardiometabolic risks in elderly people. The age-related declines in muscle strength and mitochondrial function cannot be entirely explained by the respective decreases in muscle mass and mitochondrial content. We propose that these disproportionate effects are related to altered protein homeostasis. Increased oxidative damage to proteins and DNA occurs with age, and reduced muscle protein turnover and consequent accumulation of deleterious post-translational modifications may explain these results. We developed a novel method to determine the relative abundance of old (those synthesized earlier) to new (newly synthesized) proteins in specific protein pools. Using 2-dimensional gel electrophoresis, we observe trains of gel spots (gel spot isoforms) of the same protein. Gel spot isoforms correspond to the separation of a protein that has undergone modifications altering the isoelectric pH (pl) without substantially shifting its mass. Following in vivo metabolic labeling of proteins with a stable isotope of phenylalanine, different gel spot isoforms of an individual protein have widely variable isotopic enrichment. We find that a gel spot isoforms with greater modifications (e.g.; oxidation) also exhibit lower isotopic enrichment, indicating that these proteins were formed largely before the isotope infusion. We will determine if the relative accumulation of old and damaged proteins is higher in older people and if aerobic exercise training can accelerate the removal of old proteins and replacement with newly synthesized proteins by increasing protein synthesis and degradation. Since type II fiber atrophy occurs with age, we will determine whether synthesis rates of myosin heavy chain (MHC) isoforms IIa and IIx are altered with old age. We will also determine the effect of aerobic vs. resistance exercise training on synthesis rates of individual MHC isoforms and whether age affects the response to specific exercise programs. We will also contrast the effects of aerobic vs. resistance training on accumulation of old, modified proteins. The hypothesis is that aerobic exercise will replace damaged and old proteins with newly synthesized proteins whereas resistance exercise increases synthesis of specific contractile proteins with effect on replacing old and modified proteins. We will determine whether a combined exercise program increases synthesis of specific contractile proteins as well as removal of old and modified proteins. Additional mechanistic studies are planned to determine the relative impact of reactive oxygen species production and antioxidant defense system on protein modification. The proposed studies will for the first time determine whether age increases the relative composition of old and damaged isoforms of mitochondrial, myofibrillar, and sarcoplasmic proteins and a novel mechanism by which exercise programs correct the abnormality. The proposed studies will apply novel and innovative methodologies developed in our laboratory to address important mechanistic questions that may reveal potential therapeutic targets to combat sarcopenia.

Public health relevance
Project Narrative In this ongoing research project we propose to understand the cause of age-related muscle wasting and weakness which is a major cause of frailty and morbidity of the rapidly expanding aging population. Seminal methodological advances in our laboratory will be applied to determine whether alterations in homeostasis of proteins, the molecules responsible for muscle functions could cause muscle change in elderly people. Understanding the cause of muscle weakness could pave the way for preventive and therapeutic strategies to help maintain or improve quality of life with advanced age. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The current proposal is a continuation of the original studies supported by this grant since 1992. We have recently developed a novel method to measure the accumulation of old, modified proteins. Herein we apply this method to test a hypothesis that accumulation of old and damaged muscle proteins negatively impacts the quality of the muscle protein pool and is a key factor in the deleterious effects of aging on skeletal muscle function. We previously demonstrated that the synthesis rate of muscle mitochondrial proteins (1) and myosin heavy chain (2,3) decrease with age. However, the decline in muscle mass with age is less than what would be predicted by the decline in muscle protein synthesis, suggesting that muscle protein degradation may also decrease with age. This notion is supported by an age-related decline in whole body protein turnover (synthesis and degradation) (4). Efficient degradation of old, damaged proteins and replacement by newly synthesized proteins is necessary to maintain the quality and function of the protein pool. Age-related reductions in lysosomal and proteosomal activities have been reported in animal studies (5-11). We proposes that declining muscle function with aging is not only related to decreased protein synthesis, but also decreased degradation proteins, leading to accumulation of old and damaged proteins and decreased muscle quality. We recently developed a method to measure synthesis rates of individual muscle proteins, but there is currently no method available to measure degradation rates of individual muscle proteins. We have however, successfully developed a novel stable isotope based approach to estimate the accumulation of old, damaged, and modified proteins. Our preliminary data using this method shows that old, damaged proteins accumulate in aging muscle. A major goal of the current proposal is to test a hypothesis that old, modified proteins accumulate in skeletal muscle with old age and interfere with proper muscle function. We will also determine the impact of 3 specific exercise interventions (aerobic, resistance, combined training) on protein quality. Resistance and aerobic exercise increase muscle protein synthesis rates, but their respective impact on muscle mass and function is distinct. We propose that aerobic exercise increases protein synthesis and degradation (i.e., protein turnover) such that protein quality is maintained by replacement of old proteins with newly synthesized proteins. In contrast, we expect that resistance exercise will increase protein synthesis with more modest effects on protein degradation and accumulation of old, modified proteins. We also propose that a combination of aerobic and resistance exercise may provide an optimal balance of increased proteins synthesis rates (mitochondrial and contractile proteins) while promoting maintenance of the quality of muscle proteins. A key question that we will answer in this proposal is whether older people respond to these interventions as robustly as young adults. Specific Aim 1: To test a hypothesis that damaged muscle contractile, mitochondrial, and sarcoplasmic proteins accumulate with old age. Specific Aim 2: To test a hypothesis that aerobic exercise and resistance exercise will reduce accumulation of old, modified proteins in young and older adults but this effect will be more pronounced with aerobic exercise and in the young adults. A secondary hypothesis is that resistance exercise and aerobic exercise will exhibit differential effects on synthesis rates of specific myosin heavy chain isoforms. Specific Aim 3: To test a hypothesis that a combined aerobic and resistance exercise program will have a cumulative effect but the response will be less robust in older people. To address the above specific aims we will apply a novel methodology that we recently developed using stable isotopes to measure the accumulation of damaged, modified proteins. Protein targets will be contractile proteins (actin, myosin light chain 1), mitochondrial proteins (ATP synthase ¿, cytochrome b-c complex, pyruvate dehydrogenase, succinate dehydrogenase, mitochondrial inner membrane protein), and sarcoplasmic proteins involved in energy metabolism (¿ enolase, creatine kinase and phosphoglucomutase). We will also measure the synthesis rates (total and de novo) of the above-mentioned proteins as well as 3 isoforms of myosin heavy chain (I, IIa, IIx) using a new approach that we developed. We will assess several potential mechanisms underlying the effects of aging and exercise modalities on protein quality by measuring ROS- emitting potential of mitochondria and NADPH oxidases and the content and activity of endogenous antioxidant systems. In order to asses the functional impact of the quality of proteins and interventions on clinical outcomes we will also measure mitochondrial function, insulin sensitivity, muscle mass, specific strength, and several indices of muscle performance.